IMMUNOGENICITY & EFFICACY OF DNA VACCINES AGAINST SIV INFECTION

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. There is an urgent need for an HIV vaccine that can reduce the HIV pandemic. Novel DNA vaccines that express SIV proteins are tested for immunogenicity and efficacy in the SIV-rhesus macaque model of HIV infection.